Detecting Absence Seizures Using Hyperventilation In a Home Environment

Abstract
Eysz, Inc. is developing a mobile health (mHealth) platform, the Eysz HV Recorder, to remotely diagnose and
monitor childhood absence epilepsy (CAE) to improve patient management and reduce the time to seizure
freedom. Early treatment of CAE is critical, but absence seizures are currently challenging to identify, and
diagnosis is frequently delayed. The gold standard for seizure detection is video EEG (VEEG), but VEEG has
several drawbacks for treatment management of CAE, causing most clinicians to rely on self-reports, even
though studies have shown that patients and caregivers report only about 6% and 14% of all absence seizures,
respectively. Thus, there is an urgent need for an accurate remote monitoring to assist clinicians in assessing
treatment response over time for patients with CAE. The Eysz HV Recorder is an mHealth app used to assist
clinicians in the diagnosis of CAE and is currently being used in pediatric and child neurology clinics and
undergoing a post-marketing study. The Eysz app guides patients through hyperventilation (HV) while giving
continuous feedback to safely and effectively provoke absence seizures while video-recording the patient's face.
The recording is then analyzed by a child neurologist and a report is sent to the treating physician. Our
preliminary results from our post-marketing clinical study have shown that our video analyses have a sensitivity
close to 100% and a specificity of 92% compared to VEEG for seizures greater than 7 seconds in duration.
This Fast Track SBIR project seeks to develop and test a home-based version of the Eysz HV Recorder, enabling
more frequent and convenient assessment of the patient’s treatment regimen. The FDA has requested additional
testing prior to in-home use of the Eysz HV Recorder; therefore, this Fast Track proposal seeks to develop an
in-home version of the app and validate safety protocols prior to launching an in-home study that will support
FDA clearance of the app. Phase I Aim 1: Define and validate user and system requirements to ensure safety,
usability, data quality, and regulatory compliance. Phase I Aim 2: Build and validate the software and training
materials, using a standard risk-based software development approach. We will also develop training and
educational materials for caregivers. Phase I Aim 3: Test safety procedures and app usability in a clinical setting.
We will iteratively introduce the app and training materials to cohorts of users in a clinical setting to evaluate
usability and data quality. After meeting our Go/No Go Milestones for Phase I, we will proceed to Phase II Aim
4: Perform an at-home study to assess usability, adherence, diagnostic accuracy and safety. This pivotal study
will test the use of the app by caregivers in real-life home environments. This study will provide key data to
support FDA clearance of the app and will set the stage for its future deployment as a tool for at-home monitoring
and management of CAE.

Public health relevance
Childhood absence epilepsy (CAE) is the most common pediatric epilepsy syndrome, but the associated seizures are currently difficult to detect, causing most to go undetected by caregivers. Eysz is seeking to expand their existing mobile health app, the Eysz HV Recorder, to create an innovative home-use app to remotely monitor CAE. Once completed, this work will provide a powerful and convenient tool to reliably monitor absence seizures, improving the treatment and quality-of-life of patients with CAE.